Role of Endoplasmic Reticulum Stress in Obesity-Related Endothelial Dysfunction

DESCRIPTION (provided by applicant): CANDIDATE: The candidate, Christopher L. Gentile, Ph.D., is a physiologist in the Department of Human Nutrition and Food Science at Colorado State University. Dr. Gentile's research focuses on the role of endoplasmic reticulum (ER) stress in metabolic diseases, and most recently, in the development of endothelial dysfunction. His immediate goal is to continue his postdoctoral training in order to acquire the research and professional skills necessary to successfully transition to an independent investigator. His long-term goal is to develop a successful independent, extramurally-funded research program that utilizes a translational approach (molecules to humans) to examine the molecular basis and clinical implications of ER stress in metabolic diseases. The proposed KO1 award will provide Dr. Gentile the necessary support to achieve this goal. CAREER DEVELOPMENT PLAN: Dr. Gentile's career development training in the present application consists of: 1) acquiring new research skills associated with and complementary to the proposed research plan; and 2) structured activities, including formal course-work, attendance and presentations at weekly journal clubs, university seminar series and scientific meetings, and regular interactions with his mentoring team. ENVIRONMENT: The environment for Dr. Gentile's training plan will be outstanding. The primary mentor, Dr. Pagliassotti, and co-mentor, Dr. Seals, are both internationally recognized, extramurally-funded scientists with strong records of successful mentoring in biomedical research pertaining to metabolic disease. They are complemented by an exceptional group of consulting mentors that consist of well-established investigators, each providing specific expertise in a key area of Dr. Gentile's research project and overall training plan. RESEARCH: Endothelial dysfunction is an independent risk factor for both type 2 diabetes and cardiovascular disease. The overall aim of the research project is to test the novel hypothesis that ER stress plays a role in the development of endothelial dysfunction related to metabolic diseases and lipid abnormalities. The proposed research will utilize a translational approach (molecules to humans) to examine this issue. Aim 1 will examine the mechanisms by which saturated fatty acids induce ER stress in cultured human endothelial cells, and determine whether ER stress directly mediates endothelial cell dysfunction and death. Aim 2 will examine if a high saturated fat diet induces ER stress in the vasculature of male Wistar rats, and if so, whether this ER stress mediates endothelial dysfunction that results from such a diet. Aim 3 will examine if vascular ER stress is present in obese individuals, and whether a high saturated fat meal induces vascular ER stress in lean individuals and causes a further elevation in obese individuals. Collectively, these studies could identify a novel mechanism underlying the development of endothelial dysfunction. The uniquely translational approach taken in this proposal will allow Dr. Gentile to simultaneously explore the molecular link between ER stress and endothelial dysfunction and determine the clinical implications of this link.

Public health relevance
The current proposal will examine a novel mechanism in the development of endothelial dysfunction, which is an important risk factor for cardiovascular disease and type 2 diabetes. Thus the proposed studies could provide clinically relevant information for the millions of individuals suffering from these diseases.